Mental and Physical Health in Children of Latino Migrant Farm Workers: A Multi-Level Longitudinal Examination of Risk and Resilience Factors

Abstract
Children of Latino migrant farm workers (LMFW) are a unique and vulnerable population whom are at
significant risk for social and health disparities that can have lasting developmental and socioeconomic
consequences. Every year over 3 million migrant and seasonal farmworkers harvest food across the United
States, and almost 60% have minor children whom often accompany them. Mobility produces unique
challenges for children including educational interruptions and instability, discrimination, isolation, and poverty
which can contribute to poor mental and physical health as well as early substance use. These challenges may
be especially salient during adolescence when high-risk behaviors and health disparities become more
evident. Due to the high mobility of these families, few researchers have studied this population with
consideration of the longitudinal nature of migration, and thus, have been unable to identify the long-term
effects of migration status on youth health outcomes. Also, researchers have rarely assessed resilience factors
that may mitigate stressors that LMFW youth experience. Our objectives are to longitudinally examine how
contextual migratory stressors contribute to proximal vulnerabilities that result in poor health outcomes for
LMFW youth during adolescence. We also assess specific protective factors that have potential to buffer
children from migratory risks, as well as promote health and well-being. Study participants include 400 LMFW
children aged 10-15 recruited in all three regions of the Migrant Education Program in Indiana. We use
a longitudinal mixed-methods approach that combines qualitative semi-structured interviews with quantitative
surveys collected from multiple reporters, biomarkers, and behavioral tasks to address 3 specific aims: (1)
Assess how macro and proximal risks are associated with salient health outcomes in LMFW youth, and identify
how mobility status moderates these relations; (2) Examine how macro level stressors and mobility status
affect LMFW youths’ health trajectories across adolescence, and assess how such links are mediated by
proximal risk factors; and (3) Identify protective factors that counteract or buffer negative health trajectories in
LMFW youth. This project uses a dynamic multi-disciplinary approach to assess the long-term developmental
consequences of mobility on health, while utilizing a strength-based framework to elucidate meaningful
individual, familial, and community resilience factors present in LMFW children’s environment. These outcomes
are expected to have a significant positive impact on public health issues relating to LMFW children by
informing policy and directing future intervention efforts targeted at reducing health disparities in a vulnerable
youth population during a critical developmental period. By focusing on the children of migrant farmworkers,
whom constitute one of the most economically disadvantaged and underserved Latino subpopulations, our
study lays the groundwork for future studies that aim to develop interventions to improve the life chances,
health, and adjustment of second-generation immigrant children in farmworker families.

Public health relevance
Project Narrative This longitudinal mixed-methods study examines the effects of mobility status on developmentally salient health outcomes in Latino youth from migrant farmworker families across adolescence. Additionally, we assess how mobility levels may differentiate mental and physical health and substance use outcomes in youth who remain highly mobile versus those who become settled, and identify resilience factors that have potential to protect youth from poor health outcomes. Mitigating the consequences of migratory stressors on health trajectories and identifying protective factors during a critical transition time, when health disparities are expected to become increasingly prevalent, may be one of the most significant ways to promote health and well-being among migrant children in farmworker families.